Mechanistic bases of vessel diameter regulation by Plexind1 - Resubmission

PROJECT SUMMARY
Blood vessels must be properly shaped and placed and have a hierarchical organization with characteristic
and distinct calibers to perform their vital circulatory function. In particular, vascular caliber is the primary
determinant of blood flow properties. Thus, abnormalities in luminal morphometry disrupt blood circulation
and decrease cardiovascular health. We found that Semaphorin-Plexind1 (Sema-Plxnd1) signaling, known for
its role in guiding the anatomical patterning of the vasculature, plays a novel blood flow-dependent role in
determining the caliber of the axial midline vessels (the major artery and vein of the body). Our aims are as
follows. (1) To define the signaling pathways and cellular mechanisms by which Plxnd1, its Sema3 ligands, and
blood flow regulate the caliber of these vessels. (2) To define the structural bases of Plxnd1-dependent vessel
caliber sizing and the role of Semas and flow forces as modulators of Plxnd1 expression, apicobasal targeting,
and flow mechanosensing activity. We will use zebrafish as our primary model system to exploit its unique
experimental advantages for studying vascular development, function, and signaling in vivo. We will also
perform experiments with mice to determine if the receptor's novel role is conserved in mammals. Finally, to
further illuminate how Sema ligands and circulatory forces modulate Plexin-D1 expression, localization, and
function, we will perform studies with human endothelial cell systems under tunable flow conditions.

Public health relevance
PROJECT NARRATIVE The vasculature is a network of tubes with different but characteristic diameters that delivers life- sustaining circulation everywhere in our body. Blood vessels with abnormally wide or narrow openings, either due to a genetic defect or an acquired condition like plaque buildup, cannot carry proper blood flow, leading to decreased cardiovascular health and even death. This study studies how Plxnd1, a protein found at the surface of the cells lining the blood vessels, ensures that blood vessels acquire the right caliber.